Glomerulus on a Chip: A Model to Study Glomerular Hyperfiltration

Project Summary/Abstract
Approximately 34 million people in the United States suffer from Diabetes Mellitus. Some of the early
complications of diabetes are glomerular hyperfiltration and hypertrophy. Despite being a temporary increase
in kidney function, hyperfiltration progresses into irreversible damage to the glomerular filtration barrier (GFB)
and nephron. Hyperfiltration is additionally one of the secondary effects of heart failure and can be a
precipitating cause of progressive heart failure. Being able to stop the progression of glomerular hyperfiltration
may help stem the development of diabetic kidney disease and congestive heart failure. As such, we seek to
develop a physiomimetic Organ on a Chip model of the glomerular filtration barrier to aid in studying the
progression of hyperfiltration. This model will help to facilitate an understanding of the cellular changes to the
endothelial cells and podocytes that make up the glomerular filtration barrier. To mimic the GFB, we have co-
cultured podocytes and endothelial cells on opposite sides of a porous collagen membrane scaffold. The
membrane can be transplanted into our Organ on a Chip device, and media can be run across the basal and
apical sides of the membrane in two separate channels. Our model can effectively recapitulate the effects of
both causes of hyperfiltration, osmotic and hydrostatic. Our pressure control system on the chip allows us to
control the hydrostatic pressure across our GFB, specifically adjusting the pressure in the apical and basal
culture chambers. Alteration of the media protein concentrations allows for osmotic control. Modeling
hyperfiltration will allow us to demonstrate the cytoskeletal changes, upregulation of cell-glomerular basement
membrane attachment proteins, that occur in the podocytes and endothelial cells. Additionally, we will show
that peak hyperfiltration will lead to scarring and buildup of membrane proteins in the GFB that will lead to
decreased filtration as is seen in human hyperfiltration progression.

Public health relevance
Project Narrative Organs-on-Chips are becoming an ever more popular tool to tackle the downsides of static cell cultures and animal models; while the standard models can demonstrate basic biological phenomenon, these models are inefficient for modeling disease and studying therapeutics in-vitro. While Organs-on-Chips are a better model, there is still a need to address their reliability and use in large scale studies. Here we propose improvements and experiments for a novel, organ-on-chip platform to recapitulate normal glomerular filtration, as well as glomerular hyperfiltration due to changes in hydrostatic pressure, osmotic pressure, and membrane stiffness.